Clinical Resource Core

CLINICAL RESOURCE CORE
PROGRAM SUMMARY/ABSTRACT
Diabetes represents a worldwide health crisis, with the incidence of both type 1 diabetes (T1D) and
type 2 diabetes (T2D) steadily increasing. While autoimmunity is central to T1D, many key aspects
of the disease process are shared by T1D and T2D, including beta cell dysfunction, hyperglycemia,
metabolic dysfunction and insulin resistance. Complications of T1D and T2D also have many
similarities, including cardiovascular disease (CVD) and diabetic kidney disease (DKD), both leading
causes of morbidity and mortality. The University of Colorado Anschutz Medical Center (CU-AMC)
is among world leaders in clinical translational investigations into T1D and T2D across the lifespan,
as well as in gestational diabetes (GDM) and cystic fibrosis-related diabetes (CFRD). Funding
through the Diabetes Research Center (DRC) will capitalize on these existing strengths and
catalyze the formation of an integrated comprehensive diabetes research program.
The Clinical Resource Core (CR) of the University of Colorado Anschutz Medical Campus (CU-AMC)
DRC stands at the interface of multiple institutions, programs and individuals, all of whom are working
to prevent or ameliorate the devastating long-term complications of diabetes and its high economic
burden. The CR core will leverage the current clinical research facilities and equipment available at
the Barbara Davis Center for Diabetes (BDC), CU-AMC’s Clinical Translational Research Center
(CTRC), The University of Colorado Hospital (UCH), Denver Veteran’s Administration Medical Center
(VA) and Children’s Hospital Colorado (CHCO). The DRC CR core will integrate diabetes research
across these institutions through communication and distribution of the resources available and
create shared sample and data biobanks and a recruiting database of mothers, infants, children,
adolescents and adults with diabetes, diabetes risk and controls. Such integration will accelerate
progress and increase the quality of diabetes research, coalesce existing strengths and
strategically focus faculty recruitment in areas of needed growth. DRC funding will also attract
new talent at postgraduate and junior faculty levels and add unique components of
infrastructure needed for discovery.
Specifically, we will improve access and collaborations for recruiting subjects, tracking data and
banking tissue samples from well-phenotyped participants with diabetes and control subjects across
the lifespan; establish collections of samples from our well-characterized subjects and facilitate the
ability of DRC users to perform assays from peripheral blood, serum and plasma utilizing state of the
art techniques; improve provision of specialized diagnostic and analytic services.

Public health relevance
CLINICAL RESOURCE CORE PROJECT NARRATIVE The University of Colorado Anschutz Medical Center (UC AMC) is among world leaders in clinical translational investigations into Type 1 and Type 2 diabetes across the lifespan, as well as in gestational diabetes (GDM) and cystic fibrosis-related diabetes (CFRD). Funding through the Diabetes Research Center (DRC) capitalize on these existing strengths and catalyzes the formation of an integrated comprehensive diabetes research program. The Clinical Resource Core (CR) stands at the interface of multiple institutions, programs and individuals, all of whom are working to prevent or ameliorate the devastating long-term complications of diabetes and its high economic burden. The CR core leverages the clinical research facilities and equipment available throughout the CU-AMC. The DRC CR core integrates diabetes research across these institutions through communication and distribution of the resources available, and creation of shared sample and data biobanks to recruit mothers, infants, children, adolescents and adults with diabetes, those at increased diabetes risk and controls. Such integration has already accelerated progress and increased the quality of diabetes research, by strategically focusing faculty recruitment in areas of needed growth, attracting new talent at postgraduate and junior faculty levels and adding unique components of infrastructure needed for discovery.